Breast Cancer Program

The Breast Cancer is and comprehensive, spanning basic and translational research. Program integrated The focus of this program is the study of the mechanims involved in tumor progression and growth. Utilizing the MCF10 model of human preneoplastic, proliferative disease, members of this program are able to examine the genetic factors involved in early breast cancer development, atypical hyperplasia, carcinoma in situ and the progression to invasive cancer. Translational research employs this model as a preclinical test system for preventive agents and strategies. Basic research is also dedicated to understanding the mechanism of growth promoting cell signaling in breast cells, as well as aberations in signaling during neoplastic transformation and in resistance to hormonal and chemotherapy. These studies extend to the examination of the relationship of the structure of the estrogen receptor (ER) to its function, the influence of ER second messenger cross talk and the control of proliferation/apoptosis. In addition, new concepts involving Her-2 DNA vaccines are being explored as a means of immunological control of tumor growth. Mechanisms involved in the sensitivity/resistance of breast tumors to agents controlling growth are being examined. Joint studies with other programs are being carried out to improve dietary intervention in breast cancer prevention, examine the effect of chemopreventive agents on gene expression in preinvasive breast cancer cells and development of a serum based early detection assay for breast cancer. A better understanding of the population genetics of breast cancer in African American women is being sought as welI as further elucidation of the role of the X-chromosome in this disease. Results from basic research have led to clinical protocols to test the ameliorating effect of genistein on chemotherapy, the role of heparanase in metastasis and the development of molecular strategies for early assessment of tumor injury.